Hazardous Materials Worker Health and Safety Training (U45)

Program Summary/Abstract (Overall)
Project Title: International Brotherhood of Teamsters Hazardous Materials Worker Health and
Safety Training
Application Organization Name: International Brotherhood of Teamsters
Address: 25 Louisiana Avenue, NW Washington, DC 20001
Project Director Name: Charles Austin
Contact Phone Number: 202-624-6963
Email Address: [email]
Website: teamstersafety.org
Grant Program Funds Requested: $17,186,159
(Overall)
The International Brotherhood of Teamsters (IBT) Consortium is applying for funding under the Hazardous
Waste Worker Training (HWWTP) and the Hazardous Disaster Preparedness Training (HDPTP) cooperative
agreements to provide appropriate model health and safety training.
The long-term objectives and specific aims of the IBT Consortium are to increase worker, community, and
environmental safety and resilience by training workers to appropriately respond to accidental releases of
hazardous materials, work safely on hazardous waste remediation projects, safely transport hazardous
materials via truck, rail, and air, and safely respond to natural disasters.
The IBT Consortium will access the nationwide population of targeted workers through established
partnerships with appropriate partners to deliver training to 19,920 workers in the HWWTP and 3,960 workers
in the HDPTP, for a total of 23,880 workers trained during the 5-year project period.

Public health relevance
Project Narrative (Overall) The IBT Consortium represents and has ready access to tens of thousands of workers throughout the U.S. who remediate hazardous waste sites, transport hazardous wastes, handle, package, transport and warehouse hazardous materials, and respond to hazardous materials releases. The IBT Consortium has over 1.3-million- member workforce that connects to employers, affiliates, communities, and individuals The IBT Consortium is staffed by a team of experienced worker health and safety training experts who specialize in industrial hygiene, curriculum development, adult education techniques, information technology, website and media development, data analysis, and craft-experienced worker-trainers. Through the IBT Consortium, the program has access to various stakeholders including: environmental groups, public health workers, railroad workers, and tribal entities, such as the Tribal Employment Rights Office (TERO) of the Confederated Tribes of the Umatilla Indian Reservation in the Pacific Northwest region. The combination of access to worker populations and institutional capacities enables the IBT Consortium to deliver high quality model training that complies with the NIEHS Minimum Criteria, applicable standards and regulations as promulgated by the Environmental Protection Agency (EPA), Occupational Safety and Health Administration (OSHA), and the Department of Homeland Security (DHS).